Cancer Center Support Grant (CCSG)

PROJECT SUMMARY – OVERALL
The Salk Institute is rooted in the notion that exploring the very foundations of life will benefit all. As one of the
first Basic Laboratory Cancer Centers to receive the NCI designation in 1973, the Salk Cancer Center (SCC) is
a world leader in cancer research, continuing its tradition of pioneering foundational research in cancer biology,
gene expression, epigenetics, DNA damage/repair, metabolism, and immunology, as well as training the future
generation of cancer scientists. Our central mission is basic discovery — discovery that is the foundation for
cancer prevention and therapeutics. The SCC has two Research Programs: Genome Stability, Epigenetics &
Aging in Cancer; and Tumor Immunology, Metabolism & Therapeutics. The Programs are supported by seven
highly innovative Shared Resources providing SCC members access to cutting-edge technologies, services, and
expertise. A recent major restructuring has streamlined decision-making and made leadership more responsive.
Importantly, this reorganization incorporated more diverse perspectives and expertise in leadership, while
ensuring a sustainable pipeline of emerging leaders. SCC’s Cancer Research Training and Education
Coordination Core and Plan to Enhance Diversity Core are part of the fabric of these efforts, creating a pipeline
for the next generation of diverse and exceptional cancer scientists and leaders. Through six Strategic Goals,
the SCC emphasizes collaborative and translational research while focusing on training the next generation of
scientists and ensuring a diverse cancer research workforce.

Public health relevance
PROJECT NARRATIVE – OVERALL The Salk Basic Laboratory Cancer Center is a world leader in cancer research, focusing on foundational science in cancer biology and translating discoveries to benefit patients, while training a diverse generation of cancer researchers. The Salk Cancer Center has two Research Programs: Genome Stability, Epigenetics & Aging in Cancer; and Tumor Immunology, Metabolism & Therapeutics. The Programs are supported by seven highly innovative Shared Resources providing members access to cutting-edge technologies, services, and expertise.